Skeletal Maturity and Segmental Spinal Mobility Predict Successful Vertebral Growth Modulation by Vertebral Body Tethering

Project Summary: Over 16,0000 children in the US are hospitalized for treatments of their spinal deformities.
The current surgical standard of care for these conditions is an instrumented posterior spinal fusion. These
procedures are expensive (>$100,000) and as they “fuse” the spine they result in loss of spinal growth and
mobility. Vertebral Body Tethering i(VBT) is a promising vertebral growth modulating surgical technique that
attempts to harness the body’s own growth potential to correct spinal deformities. Despite VBT’s promising
benefits, predicting which patient might benefit most from the procedure has been challenging. This project
seeks to further refine a computational based surgical decision tool, using novel surgical devices and large
animal model. The objective of the current proposal is to incorporate differences in growth potential (skeletal
maturity) and vertebral segment mobility (“curve stiffness”) elucidated in our animal model, into our
computational model so that the computational model can be used pre-operatively or intra-operatively to inform
surgical decision-making using patient specific data. The long-term goal of this project is to provide
personalized, vertebral-level by level strategies in correcting spinal deformities that maximize vertebral growth
modulation and minimize the use of spinal fusion. We will accomplish this through the following aims:
Aim 1: To characterize the maturity-related changes in the hyperkyphotic porcine vertebral physis and their effect
on the sensitivity to vertebral tether load. Hypothesis: The vertebral physis will thin and stiffen with age, becoming
less sensitive to mechanical load. Approach: Porcine vertebral phases of different maturity will be characterized
and growth modulation response to VBT will be measured.
Aim 2: To incorporate skeletal-maturity related data into our computational model and then test its ability to
account for independent differences in vertebral segment mobility. Hypothesis: Growth modulation following
VBT is directly related to vertebral segment mobility independent of skeletal maturity. Approach:
Computational modeling throughout clinically relevant pre-operative and post-operative disc geometries will be
performed; a subset of scenarios will be surgically reproduced to assess the computational model’s predictions
and further refine parameters if necessary
Aim 3: To translate our computational model into a clinically predictive tool to guide operative intervention.
Challenge: To obtain pre-operative and intra-operative data for our computational model to allow clinical
predictions of vertebral endplate stress to guide treatment.
Together these aims will further elucidate the effects that skeletal maturity and vertebral segmental mobility
have on vertebral growth modulation and allow translation of our research-based computational model into a
predictive clinical tool. This will allow better patient and vertebral level selection, minimize unnecessary revision
surgery, and limit the use of growth- and motion- eliminating spinal fusions.

Public health relevance
Project Narrative This project seeks to obtain fundamental knowledge using biological systems to refine a computational decision-making tool capable of predicting the outcome of vertebral body tethering on patient by patient and vertebral level by level basis. This will optimize patient outcomes and minimize the morbidity associated with spinal deformity correction.